Berkeley Population Center - Development Core

SUMMARY/ABSTRACT – DEVELOPMENT CORE
The BPC Development Core is designed to advance innovative research and cultivate new investigators. This
goal is achieved through mentored support, a pilot grant program, and production of a rich array of networking
events and interdisciplinary workshops. The Pilot Grant Program funds new data collection and analyses that
fit within the BPC's five primary research areas and show promise of leading to external funding, with a priority
on NICHD Population Dynamics Branch program areas. Development core funds are also used to conduct
networking events aimed at fostering new research endeavors. Through collaboration with other units on
campus, the Core is able to cultivate interdisciplinary projects. New investigators are provided mentoring and
introductions to established researchers at UC Berkeley and other local institutions, e.g., at UCSF or Stanford.
Through its pilot program and beyond, the Core identifies research projects that show promise for external
funding and supports the development of major proposals that will take them to the next stage. In addition to
the publications produced as a result of the research, BPC disseminates findings via its various online media
outlets. The result is a contribution to emerging research areas with innovative methods and new forms of
data, all designed to address health challenges.